Xenbase - Dissemination

Component: DISSEMINATION
PROJECT SUMMARY/ABSTRACT
Dissemination and training are at the core of Xenbase’s mission to accelerate the translation of
research using Xenopus into knowledge that will impact human health. Our goals are to enable
research using Xenopus, make high-quality curated data available to Xenopus researchers,
facilitate the dissemination of Xenopus data to the broader biomedical community, and to help
improve data literacy in the Xenopus community. We follow the FAIR data management principles
which aim to make data Findable, Accessible, Interoperable and Reusable. We curate data, link
data from Xenopus to humans and model organisms and provide curated datasets to external
resources including: NCBI, UCSC, GO Consortium, UniProt, Ensembl and other model organism
knowledgebases (MOKs). We plan to establish new exchanges with a number of resources such
as the Monarch Initiative, the Alliance of Genomic Resources (AGR), DIOPT and the European
Bioinformatics Institute. All our code, bio-informatic pipelines and processed data reports are
freely available. Xenbase also provides critical data-sharing infrastructure for many other NIH-
funded projects, most notably the Xenopus genomes. Xenbase has also become a focal point for
the Xenopus community and we provide outreach, education, and training activities. In sum,
Xenbase has become the single most important clearing house of data from Xenopus research
and the communication hub for the Xenopus community.
Aim 1. Continue open access dissemination of Xenbase content using the FAIR principles.
Aim 2. Enhance dissemination by improving the user interfaces and data-sharing infrastructure.
Aim 3. Community Communication, Outreach, and Training.